Molecular, Cellular and Behavioral Impact of the R203W PACS1 Syndrome Mutation

Project Summary
PACS1 Syndrome is a recently identified neurodevelopmental disorder caused by a recurrent de novo missense
mutation in PACS1 (p.Arg203Trp). Patients carrying this missense mutation share several developmental deficits,
including intellectual disability, seizures and autism. The mechanism by which PACS1R203W causes PACS1
Syndrome is unknown and no curative treatment is available. PACS1 is a multifunctional sorting protein that
facilitates retrograde trafficking from endosomes to the trans-Golgi network, for delivery of proteins to the primary
cilium and for genome integrity. This multifunctionality depends on a small segment of PACS1 called the furin-
binding region (FBR), which binds a broad range of client proteins and signaling molecules. The R203W mutation
is located in the FBR, and our biophysical studies reveal a change in the FBR dynamics when the R203W
substitution is present, suggesting the possibility of an altered interaction between PACS1 and one or more of
its client proteins in PACS1 Syndrome. Our preliminary studies strongly suggest PACS1R203W increases binding
to the deacetylase HDAC6 to profoundly disturb membrane traffic and impair neuron development. Consequently,
PACS1R203W reduces acetylation of known HDAC6 substrates, including α-tubulin, disrupting centrosome
positioning and leading to Golgi fragmentation and increased dendritic arborization in pyramidal neurons. This
dendritic overbranching is coupled to reduced inhibitory currents in L2/3 cortical neurons resulting in an increased
excitatory:inhibitory (E:I) ratio, similar to that found in other neurodevelopmental disorders, suggesting that
PACS1R203W severely affects neuronal function and behavior. Our long-term goal is to understand how
PACS1R203W causes disease and to use this information to develop effective therapies. The objective of this
particular application is to determine how PACS1R203W and HDAC6 combine to dysregulate neuronal arborization
and synaptic transmission. We hypothesize that the aberrant interaction between PACS1R203W and HDAC6 alters
organellar positioning, which contributes to excessive dendrite arborization and dysregulated synaptic activity.
Guided by strong preliminary data, we will test our hypothesis by pursuing three specific aims: 1) Determine how
the R203W mutation alters PACS1 structure and dynamics for influencing client protein interactions, 2)
Determine how PACS1R203W and HDAC6 combine to dysregulate Golgi positioning and dendrite arborization,
and 3) Determine how PACS1R203W alters synaptic activity and behavior. The approach is innovative because
we will characterize, from the atomic structure to the whole-organism, the mechanism by which the recurrent
R203W substitution causes neuronal dysfunction. This research is significant because it may identify new targets
and therapeutic approaches to treat this debilitating disorder.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will unravel the mechanisms by which a novel protein complex disrupts neuronal function, resulting in severe and debilitating neurodevelopmental consequences, including intellectual disability, epilepsy and autism. Thus, the proposed research is relevant to the NIH’s mission of supporting fundamental research that will ultimately cure disease.